Role of caregiver-adolescent interpersonal and cultural factors on Latinx adolescent tobacco use: A mixed-methods study

Project Summary
The early onset of tobacco use among Latinx adolescents in the United States is a growing public
health concern as it increases adolescents’ risk of developing a dependency on tobacco products and related
chronic health diseases in adulthood. The expected growth and prevalence of substance use in the
Mexican-origin population underscores the importance of improving our understanding of the familial and
cultural factors that may prevent the early onset of tobacco use among Latinx adolescents. Some
well-established cultural factors of relevance to substance use prevention and intervention efforts among the
Latinx community include adherence to Latinx cultural values such as familismo (the value of family loyalty)
and respeto (respect for authority figures). However, literature has largely ignored the role of Latinx
caregiver-adolescent dynamics (e.g., caregiver-youth cultural value differences, family conflict, and parental
monitoring) on aggravating adolescent tobacco use. Thus, the present study takes a culturally-sensitive
approach to understanding Latinx adolescent tobacco use and its influences via consideration of the
system-level influences of family, culture, and their interactions over time. This project’s overarching goal will
be achieved via three specific aims: (1) examine the association between cultural values and adolescent
tobacco use over time; (2) examine the association between parental monitoring, family conflict, and
adolescent tobacco use over time; and (3) examine the relation between caregiver-adolescent cultural value
discrepancies, family conflict, and adolescent tobacco use over time using a mixed methods approach. The
aims will be addressed by leveraging data collected as part of the California Families Project (CFP), an
ongoing longitudinal study of 674 Mexican-origin caregiver-adolescent dyads from the Sacramento and
Woodland, CA, school districts. CFP survey measures include questions regarding caregiver- and
adolescent-reported cultural values (i.e., familismo and respeto), parental monitoring practices, family conflict,
and tobacco use. The second phase of the proposed mixed methods study will involve four focus groups (two
caregiver and two youth groups) of six participants each (N = 24) from the Richmond and Greater Richmond,
VA, area and will explore perceived cultural value differences, other tobacco use influences, family
communication about tobacco use, and ATP use. Findings from this study will contribute to NIDA’s goal of
identifying and developing approaches to reduce health disparities by elucidating the ecological factors that
promote or impede prevention, treatment and recovery of substance use among Latinxs. Moreover, the
research and training outlined in this NRSA F31 predoctoral fellowship application will equip me with the skills
and mentoring needed to pursue a career as an independent researcher, including knowledge of substance
use research, advanced statistical methods, the responsible conduct of research, grant and manuscript writing
proficiencies, and translating research into culturally tailored community interventions.

Public health relevance
Project Narrative Since the early onset of tobacco use among Latinx adolescents in the United States is a growing public health concern, a culturally-sensitive and ecological approach to understanding Latinx adolescent tobacco use and its influences is needed. This proposed project examines the longitudinal associations between (1) cultural values and adolescent tobacco use; (2) parental monitoring, family conflict, and adolescent tobacco use; and (3) caregiver-adolescent cultural value discrepancies, family conflict, and adolescent tobacco use over time using a mixed methods approach. The findings from this study will inform the present understanding of ecological factors that promote or prevent tobacco use among Latinx adolescents and thus, have critical implications for early intervention efforts.